The Amyloidosis Forum: Advancing Drug Development in ATTR Amyloidosis in an Evolving Treatment Landscape.

Project Summary/Abstract
The Amyloidosis Research Consortium (ARC), established in 2015, is a patient-led nonprofit
organization. The mission of ARC is to build mutually beneficial collaborations between
government, academia, industry, patients, and regulatory agencies to systematically address
critical barriers and challenges that slow the development of new therapies for systemic
amyloidosis.
In 2019, ARC entered a public-private partnership (PPP) with the US Food and Drug
Administration (FDA) to bridge scientific gaps in drug development, known as the Amyloidosis
Forum. The Amyloidosis Forum provides a unique opportunity for the multidisciplinary, cross-
stakeholder amyloidosis community to come together to identify and bridge the scientific gaps
that act as barriers to drug discovery and development for the treatment different types of
amyloidosis. The PPP framework includes convening meetings to align the field, resulting in
formalized working groups to accelerate action. In 2022, the PPP obtained approval from the FDA
to expand the remit of the Amyloidosis Forum to include transthyretin amyloidosis (ATTR) in
recognition of the unmet needs and challenges that prevail in current and future therapeutic
development.
The first generation of drug approvals in ATTR has reshaped the research landscape creating the
need to reconsider how to effectively design trials against a backdrop of treatments that slow
progression of the disease. This Forum meeting will set the stage by sharing the advancements,
evaluating the impact and unmet needs that currently exist, and identifying key initiatives with the
aim of leveraging cross-stakeholder resources to collaboratively act on field-shaping priorities.
Addressing themes related to Advancing Drug Development in ATTR in an Evolving Treatment
Landscape, our Specific Aims include:
Specific Aim 1: Understand the impact of novel treatments and the current unmet needs in
patients with ATTR.
 Review and discuss advances in the field of ATTR including approaches to treatment and
the selection of new therapies, the assessment of the role of combination therapies, and
how progression and response is measured in real-world settings.
 Bring greater context to the above themes through patient participation, particularly with
respect to persistent healthcare inequities.
Specific Aim 2: Define new approaches to designing clinical trials in ATTR.
 Establish a common understanding of the current and anticipated challenges facing drug
development in ATTR for the next generation of clinical development programs.
 Assess the potential role of biomarkers and evidence gaps, evaluate the strength of
various biomarkers, endpoints, and trial designs, and define collaborative approaches to
assessing these for application in trial design.
Specific Aim 3: Outline regulatory approval and reimbursement challenges and define
forward-looking action plans.
 Provide an understanding of the current and anticipated challenges facing regulatory
approvals and reimbursement in ATTR.
 Outline actions to address these challenges for the next generation of therapies.

Public health relevance
Project Narrative Transthyretin amyloidosis (ATTR) is a rare, multisystemic disease that shares many features with more common geriatric syndromes. Two sub-populations have emerged with disproportionate impact and high unmet need: people of West African descent with the autosomal dominant hereditary (ATTRv) Val122Ile variant and those with an acquired wild-type form of disease (ATTRwt). Both ATTRv and ATTRwt patients present with cardiac symptoms almost exclusively in older adults (>60 years). While ATTR is substantially underdiagnosed and frequently misdiagnosed, evidence suggests that heart failure, commonly attributed to coronary heart disease, may in fact be due to an amyloid-induced cardiomyopathy in a significant percentage of the aging population. The Amyloidosis Forum, a Public Private Partnership between The Amyloidosis Research Consortium and FDA, will expand its remit to include ATTR in recognition of the unmet need and challenges that prevail in current and future therapeutic development. This meeting will focus on Advancing Drug Development in ATTR in an Evolving Treatment Landscape, through understanding the impact of novel treatments and unmet need in patients with ATTR, defining new approaches to designing clinical trials in ATTR, and outlining actions to address regulatory approval and reimbursement challenges.